Molecular Assembly on the Cell Surface of Actinomyces

PROJECT SUMMARY
Dental plaque represents one of the most complex microbial communities or biofilms known to affect humans.
Oral biofilm-related diseases, e.g. dental carries, gingivitis, and periodontitis, impact a large population of all age
groups and continue to impose a huge economic burden due to the lack of effective therapies. The development
of dental plaque begins with the attachment of early colonizers to the tooth enamel, generating an adhesive
matrix that attracts intermediate and late colonizers. Actinomyces spp. are key early colonizers that play a
prominent role in biofilm development by their ability to interact directly with the tooth surface and both early and
intermediate colonizers. Therefore, our studies have focused on dissecting the adhesive properties, i.e. pilus
and non-pilus proteins, dictating these interactions and their assembly mechanism on the surface of Actinomyces
oris, the most abundant Actinomyces species in the human oral cavity. During the past grant period, we identified
a transmembrane protein named SafA in A. oris that is genetically linked to the housekeeping sortase SrtA (class
E sortase), the conserved transpeptidase enzyme that is central to the morphogenesis and cell wall anchoring
of pilus and non-pilus proteins. Specifically, safA deletion results in SrtA cleavage by signal peptidae LepB2 and
extracellular excretion of SrtA, concomitant of secretion of non-pilus proteins and most pili, while the remaining
cell-wall anchored pili are exceedingly long but unable to mediate bacterial coaggregation. Strikingly, the defects
of ∆safA in SrtA membrane localization, cell wall anchoring of pili and surface proteins, and coaggregation can
be rescued by ectopic expression of SafA homologs from Corynebacterium matruchotii and Corynebacterium
diphtheriae, suggesting the conservation of SafA-associated mechanism in Actinobacteria. Remarkably, the
∆safA mutant is severely defective in coaggregation with Porphyromonas gingivalis (Pg) and in inhibition of Pg
growth, in contrast to wild-type cells. Intriguingly, in Bifidobacterium the housekeeping sortase SrtE contains a
C-terminal SafA domain, suggesting the co-evolutionary existence of class E sortases and SafA. Therefore, we
propose that SafA is an evolutionarily conserved antagonist of signal peptidase that topologically modulates
sortase function in polymicrobial interaction and biofilm formation. Using biochemical, genetic, and structural
approaches, we aim to test this central hypothesis by elucidating the antagonistic mechanism of SafA-mediated
topological modulation of sortase function in polymicrobial interaction and biofilm formation in A. oris, determining
the conservation of this SafA-associated mechanism and the co-evolutionary existence of class E sortases and
SafA in Actinobacteria, and examining how the SafA-associated mechanism modulates A. oris coaggregation
with Pg and Pg virulence. The conservation of sortase-mediated surface assembly and SafA-associated
mechanism in Actinobacteria thus magnify the significance of our studies on how SafA topologically modulates
sortase function in A. oris that likely affects the virulence potential of other oral pathogens.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT This study examines how adhesive factors on the cell surface of the oral colonizer Actinomyces oris are built and mediate bacterial interactions leading to formation of dental plaque. The results generated may provide novel strategies for the prevention, control, and treatment of dental plaque-related diseases.